Mentoring Clinical Investigators in Patient-Oriented Adolescent Alcohol Research

PROJECT SUMMARY/ABSTRACT
This K24 Midcareer Investigator Award will provide Dr. Lindsay Squeglia with protected time to conduct research
in adolescent alcohol use disorder treatment development, mentor junior clinical investigators in adolescent
alcohol research, and continue her own career development in patient-oriented alcohol use research initiatives.
The research aims of this grant are focused on utilizing inflammation markers, neuroimaging, and neurocognitive
assessment to test a potential pharmacological agent to treat adolescent alcohol use disorder. This study will
provide a strong training platform for junior investigators interested in patient-oriented alcohol research to gain
experience in clinical trial methods, adolescent substance use assessment, alcohol and inflammation
biomarkers, neuroimaging, neurocognitive assessment, pharmacotherapy development, and statistical analysis.
It will also provide a platform for Dr. Squeglia to develop a new direction for her patient-oriented research by
incorporating peripheral measures of inflammation and central measures of neuronal health, which could provide
additional venues for identifying both treatment efficacy markers and candidate treatments for adolescent alcohol
use disorder. Expanding on success to date, mentoring emphasis will be placed on increasing the participation
of individuals from minoritized backgrounds in conducting alcohol research. She will utilize her network of
national and international collaborators to provide networking opportunities for mentees and broad dissemination
of research findings. Career goals will focus on areas critical to growth and development as a mentor and leader
and will help ensure continued success with independent funding in neuroscience-informed alcohol use disorder
treatment development. Goals will be achieved through hands-on research experiences guided by experts in the
field; coursework; seminars, workshops, and conferences; and leading publications with trainees and expert
colleagues in the field. In sum, this award will provide a platform for training the next generation of adolescent
alcohol use researchers and expand the reach of adolescent alcohol use treatment research.

Public health relevance
PROJECT NARRATIVE The K24 Mid-Career Investigator Award will allow Dr. Squeglia to bolster her dedication to patient-oriented adolescent alcohol research and mentorship. She will also develop her own skill set through proposed structured trainings in inflammation markers, advanced neuroimaging, and statistical analysis. Dr. Squeglia is committed to training the new generation of patient-oriented adolescent alcohol researchers and will continue to concentrate on efforts to diversify the pool of junior alcohol researchers.